Improving access to multi-lingual health information through machine translation

DESCRIPTION (provided by applicant): The results of our proposed research will extend the usability of MT in healthcare and serve as a foundation for further research into improving the availability of health materials for individuals with Limited English Proficiency. Our description of public health translation work from Aim 1 will provide new understanding of existing barriers to translation. The error analysis from Aim 2 will identify specific focus areas for improving MT. Aim 3 will provide fundamentally new MT technology designed to adapt generic systems to the health domain, as well as a prototype implementation of a domain-adapted post-processing module. The evaluation studies in Aim 4 will provide a model for evaluation of machine translation technologies and provide benchmarks from which to evaluate advances in the machine translations for health materials in the future. Ultimately, this work will advance us towards the long term goal of eliminating health disparities caused by language barriers and improve access to pertinent multilingual health information for those with limited English proficiency. Review CriteriaSignificanceInvestigator(s)InnovationApproachEnvironmentReviewer 121321Reviewer 212121Reviewer 333453

Public health relevance
PROJECT NARRATIVE The ability to access health information in the U.S. depends greatly on the ability to speak English. Yet a growing number of people in this country speak a language other than English. We propose to develop novel domain-specific natural language processing and machine translation technology and evaluate its impact on the process of producing multilingual health materials. Ultimately, this work will advance us towards the long term goal of eliminating health disparities caused by language barriers and improve access to pertinent multilingual health information for individuals with limited English proficiency. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Whether determining to stay home with the flu, to vaccinate your child, or to engage in safe sex, all of us depend on written health information to make decisions affecting our personal health. Effective communication of health-related information is a key component of public health practice and is particularly critical in responding to disease outbreaks or in disaster preparedness, where frequent health information updates must be rapidly communicated. For the over 46 million people living in the United States with limited English proficiency (LEP), obtaining accurate and up-to-date health information can be very challenging as a result of language barriers, cultural barriers and low health literacy (Peña-Purcell, 2008; Cardelle, 2005). Despite federal regulations mandating improved access to health information for LEP individuals, public health materials in languages other than English remain scarce. The long term objective of this proposed research is to increase the availability of multilingual public health information for LEP populations through the advancing domain-specific machine translation technology. Current translations of consumer health materials are generated manually at great expense (Garcia-Castillo, 2007; Valenzuela, 2008). We propose to develop novel domain-specific natural language processing and machine translation (MT) technology and evaluate its impact on the process of producing multilingual consumer health materials. Our goal is to expand the availability of health information for LEP populations while maintaining accurate, readable content. We propose to do this through three specific aims: Aim 1: Advance our understanding of the current processes used by health departments to translate public health documents for Limited English Proficiency populations. Using Cognitive Work Analysis as a conceptual framework, we will first develop a rich description of current translation processes in a variety of public health settings. We will then explore existing obstacles, such as the lack of standard processes and the burden of costs, to producing quality public health materials for LEP populations in a timely manner. These studies will serve as the foundation for the evaluation of our domain specific machine translation approach in Aim 4. Aim 2: Gain insights into the strengths and weaknesses of current generic machine translation technology applied to the health domain. We will develop a taxonomy of errors produced by generic state-of-the-art statistical MT technology when applied to documents from the public health domain. This taxonomy will be used in an error analysis of a large set of automatically translated documents, which will generate a precise understanding of the current capabilities and shortcomings of MT in the public health domain. Aim 3: Develop novel techniques for adapting machine translation technology in the domain of health. We will develop novel computational algorithms to address the most important weaknesses identified by the error analysis in Aim 2. These will be designed to improve the portability of MT and related natural language processing applications to novel health domains, which will ultimately allow for a more pervasive use of MT in healthcare settings. Aim 4: Evaluate the impact of machine translation on the production of multilingual health materials. We will evaluate the effect of our newly developed domain-specific MT technology on the creation of health materials for Limited English Proficiency populations in a variety of public health settings. We will measure the impact of domain-specific MT on the time and costs of producing translated materials for LEP populations and validate the accuracy and cultural acceptability of the materials with public health professionals and community members. Expected outcomes: At the end of the funding period we expect to have the following results: " A comprehensive taxonomy of common errors encountered in MTs of health materials " A quantitative error analysis based on a large, representative set of automatically translated public health documents in at least two key target languages " Novel domain-specific MT technology for producing multilingual health materials. " A rich description of current practices and processes used by public health departments to create translations of health materials for LEP populations " A detailed analysis of the barriers to the efficient translation of health materials for LEP populations " An assessment of the impact of domain-specific MT on the current process of producing health materials for LEP populations. These achievements will help the National Library of Medicine (NLM) in meeting their goal of supporting trusted information services that promote health literacy and the reduction of health disparities (NLM, 2007).